IARC Monographs on the Identification of Carcinogenic Hazards to Humans

Project Summary/Abstract
Since 1971, the IARC Monographs on the Identification of Carcinogenic Hazards to Humans
has provided an evidence-based approach to identifying the preventable causes of human
cancer. Organizations worldwide rely on the IARC Monographs as a trustworthy source of
carcinogenicity evaluations in their efforts to control cancer. Agents evaluated by the
Monographs encompass chemicals, physical and biological agents, complex mixtures,
occupational exposure circumstances, and other exposures of everyday life. To date, 1021
agents have been evaluated, with 121 classified as “carcinogenic”, 89 as “probably
carcinogenic”, and 315 as “possibly carcinogenic” to humans. Agents are selected for
evaluation based on evidence of human exposure and of carcinogenicity, and public health
importance. Monographs are developed by independent global experts without conflicts of
interest. Each Monograph includes systematic reviews of the pertinent scientific literature
covering three unique streams of evidence (cancer in humans, cancer in experimental
animals, and mechanistic evidence). The

Public health relevance
Narrative The Programme of IARC Monographs on the Identification of Carcinogenic Hazards to Humans identifies the preventable causes of cancer by convening expert working groups to conduct authoritative, internationally respected evaluations of suspected carcinogens, encompassing chemicals, physical and biological agents, complex mixtures, environmental and occupational exposures, and other exposures of everyday life. The resulting IARC Monographs are made freely available online to the public, and results are also disseminated through the scientific literature and other media. The IARC Monographs provide governments and health agencies worldwide with timely, trustworthy, authoritative scientific information to support actions to prevent cancer through control of exposure to known, probable, and possible human carcinogens.